Administrative Core

Project Summary/Abstract: The Administrative Core is responsible for the managerial oversight of all Johns
Hopkins Prostate SPORE Program activities. In addition, the Core continues to facilitate interactions between
Johns Hopkins Prostate Cancer SPORE Investigators and investigators associated with other Prostate Cancer
initiatives. The managerial structure of Johns Hopkins Prostate Cancer SPORE, with its Principal Investigator,
Steering Committee, Internal Oversight Committee, and External Scientific Advisory Board, has been designed
to promote translational research by creating a prostate cancer research culture and transcends academic
departments, medical disciplines, and individual research skills, and providing high quality monitoring,
evaluation, and oversight of the SPORE portfolio of Research Projects, Core Resources, the Career
Enhancement Program, and the Developmental Research Program. The Administrative Core provides
communications, resources, including teleconferences, travel funds, and administrative staffing for all its
managerial activities.